Lung Cancer Screening: Cumulative Risk and Multilevel Impact of False Positive Findings

ABSTRACT
The National Lung Screening Trial demonstrated the efficacy of lung cancer screening (LCS) with low-dose
computed tomography in reducing 5-year lung cancer mortality by 20%, albeit with high rates of false-positive
results. The US Preventive Services Task Force recommends annual LCS with LDCT for individuals ages 50-
80 years who currently or formerly (quit within 15 years) smoked with a 20-pack-year history. Despite the task
force Grade B recommendation, a major concern of LCS is the potential harm associated with false-positive
results which are defined as having one or more nodules requiring follow-up and no change or lung cancer
diagnosis after one year. Specifically, false positives may burden the patient, clinician, and healthcare system
due to the economic and psychological effects of extra imaging and invasive procedures, fear of missing
cancer, and complications from procedures for benign lesions. There is a need to better estimate the burden
and the factors that affect false positive results in real-world practice over multiple rounds of screening to
inform patient-clinician conversations, guide the development of interventions to reduce false positive rates,
and optimize the risk-benefit ratio of LCS. The primary objective of this proposal is to identify the burden of
false-positive results at the patient, clinician, and facility levels and to understand the impact of false-positives
across the screening continuum. Using rich sources of longitudinal LCS data for >40K LCS exams from 17
facilities linked with state-based cancer registry data, we will accomplish the objectives through the
following specific aims (1) Identify attitudes, knowledge, and experiences with false-positive results from LCS
among patients and clinicians; (2) Determine patient-, exam-, radiologist-, and facility-level factors that affect
false-positive findings on lung cancer screening; (3) Assess the cumulative risk of a false-positive LCS exam
over 5- and 10- rounds of annual screening across multilevel factors. An estimated 14.5 million US adults are
eligible for LCS and are at risk of experiencing a false positive result. This study will generate in-depth
knowledge about the potential harms of false-positive LCS results. These findings may inform patient-clinician
shared decision-making conversations or may help to reduce false positive rates by identifying modifiable
radiologist or facility-level factors.

Public health relevance
NARRATIVE The proposed study will generate population-based data on the impact of false-positive findings from lung cancer screening with low dose computed tomography for the 14.5 million U.S. adults eligible for screening. These results have the potential to inform patient and clinician shared decision-making conversations and future US Preventive Services Task Force evidence reviews. As the number of patients screened for lung cancer increases due to expanded eligibility criteria, this research is timely and responsive to the National Cancer Institute’s goal to support research in cancer control that will help inform guideline development and policy decisions.